DECREASING SEVERITY OF RECURRENT HEPATITIS C IN LIVER

Based on observations we have recently made, there is evidence that the recurrence of hepatitis C virus (HCV)-induced liver disease in transplanted livers may be reduced by the careful selection of the donor. We hypothesize that chronic active hepatitis due to HCV is not merely the result of cytopathic effects of the virus but that the immune response plays a role in the pathogenesis of the disease. Our findings suggest that HLA-class II - restricted immune responses may contribute to the pathogenesis of HCV-related liver injury in liver transplant recipients. Our studies show that recurrence of the disease in a transplanted liver appears to be accelerated if the recipient and donor share certain HLA-class II alleles. We propose to extend our studies to a larger number of patients to establish the extent of the prevention. We propose to study the role played by HLA-DQ and HLA-DR in presenting HCV peptides and to identify the recipient lymphocytes which recognize the HLA-DQ-peptide complex. The goals of these studies will be to aid in our understanding of HCV pathogenesis and prevent disease in the transplanted liver which will result in a significant savings of health care resources. Thus, the specific aims are to: Aim 1. to verify the association of HLA-DQ sharing and recurrent disease by extending our preliminary study to 100 liver allograft recipients whose primary disease was chronic active hepatitis (CAH) due to HCV infection. These patients will be characterized after transplantation by: a) identification of HLA class II genes in recipients and liver donors; b) correlation of class II matching with disease end points determined under clinical protocol: determination of HCV viral titers; identification and quantification of antibody to HCV peptides; and, determination of the status of graft using serial biopsy to identify rejection or disease recurrence. Aim 2. to characterize lymphoid cells infiltrating grafts. Studies will contrast patients with recurrent disease and those with rejection, infection or no pathologic indication. Lymphocytes in frozen section from serial biopsies will be characterized by: a) immunohistology for CD antigen expression by lymphocytes consistent with helper or cytotoxic T cell phenotypes; b) in situ hybridization for cytokine gene expression in lymphocytes to characterize them as belonging to the TH0, TH1 or TH2 subsets of T helper cells; c) in situ hybridization for HCV to identify the cells where virus is replicating with simultaneous staining for HLA-DQ expression to determine if virus is replicating in cells expressing HLA- DQ. Aim 3. to determine whether HLA-DQ presents HCV peptides to T cells in recipients with recurrent disease by: a) peptide binding assay to investigate whether HCV peptides bind to HLA-DQB; b) in vitro assays to measure stimulation of recipient T cells by liver donor's cells presenting HCV peptides.